Systems analyses of induction and maintenance of immunity to SARS-CoV-2 vaccination in kidney transplant recipients receiving mycophenolate mofetil immunotherapy

PROJECT SUMMARY/ABSTRACT
Immunocompromised patients, including those requiring immunosuppressive therapy following organ
transplantation, are at high risk for severe disease from SARS‐CoV‐2. As SARS-CoV-2 rapidly transitions from
a pandemic virus to endemic status, like influenza, seasonal vaccinations against emerging variants will likely
become the primary tool for limiting morbidity and mortality. While the efficacy of vaccination against SARS-CoV-
2 has been very promising, specific populations have been identified who are at increased risk of failing to
develop protective immunity. Immunocompromised populations respond poorly to SARS-CoV-2 vaccination,
particularly solid organ transplant (SOT) recipients receiving immunosuppressive therapy. Within SOT recipients,
the type and dose of immunosuppressive therapy have further been shown to impact vaccine efficacy. Patients
receiving mycophenolate mofetil (MMF) immunotherapy, which functions by preventing B and T cell
proliferation/activation, as well as leukocyte recruitment, have the poorest humoral and cellular response post-
vaccination for SARS-CoV-2. Preliminary evidence suggests that discontinuing MMF before vaccination
improves humoral responses in SOT recipients. This project will test the hypothesis that coordinated innate and
adaptive dysregulation pre-vaccination driven by MMF immunosuppressive therapy diminishes the quality,
quantity, and durability of cellular and humoral immunity to SARS-CoV-2 in kidney transplant recipients. In Aim
1, we will characterize the impact of MMF on the generation, quality, and maintenance of adaptive immune
responses to SARS-CoV-2 vaccination in SOT recipients. We will use validated assays to quantify and
functionally profile humoral and cellular immunity to SARS-CoV-2. In Aim 2, we will define the pre-vaccine
immunological determinants of a protective host immune response to SARS-CoV-2 vaccination in kidney
transplant recipients and identify the mechanisms of MMF-diminished immunity. We will use systems biological
tools to comprehensively profile, at the single-cell level, the peripheral immune system prior to vaccination. In
Aim 3, we will determine how pre-vaccine MMF reduction impacts the host immune response to SARS-CoV-2
booster vaccination in kidney transplant recipients.
Together, these data will provide a comprehensive, mechanistic understanding of how MMF immunotherapy
dysregulates the immune system in SOT recipients and how this dysregulation impacts the induction and
durability of protective immunity against SARS-CoV-2. This knowledge will allow the development of targeted
strategies to correct or circumvent MMF-driven immune dysregulation, thereby permitting efficacious responses
to SARS-CoV-2, and other vaccines, in SOT recipients and other at-risk populations.

Public health relevance
PROJECT NARRATIVE SARS-CoV-2 is transitioning from pandemic status to becoming an endemic virus, like influenza, and seasonal vaccinations will likely become the primary method for limiting disease. Despite the overall effectiveness of vaccination against SARS-CoV-2, some people are at increased risk of not developing protective immunity, most notably immunocompromised populations such as solid organ transplant recipients on life-long immunosuppressive medications. This research aims to determine how immune dysregulation before vaccination, driven by differences in mycophenolate mofetil immunosuppressive treatment, impacts the development and long-term maintenance of protective immunity against SARS-CoV-2, and ultimately how this dysregulation can be corrected to improve responses to vaccination in this and other at-risk populations.